2009 Drinking Water Disinfection Byproducts Gordon Conference

DESCRIPTION (provided by applicant) The investigators request funding for a recurring Gordon Research Conference, entitled, "Drinking Water Disinfection By-products (DBPs): Integrating Occurrence and Formation, Exposure, Toxicity, and Epidemiology". It will be held at Mount Holyoke College in Massachusetts, on August 9-14, 2009. This conference aims to include the latest research on DBP occurrence, formation, exposure, toxicity, and epidemiology with the goal of facilitating dialog between chemists, toxicologists, epidemiologists, and engineers in this research area, and integrating collaborative epidemiologic, toxicology, exposure, and occurrence and formation studies to solve DBP issues. Issues to be covered include formation chemistry, human exposure, risk assessment, and new cancer studies.

Public health relevance
Proposal Narrative The proposed Gordon Research Conference, on 'Drinking Water Disinfection By-products (DBPs): Integrating Occurrence and Formation, Exposure, Toxicity, and Epidemiology' has a direct bearing on public health, as millions of people are exposed to drinking water DBPs, and DBPs have been implicated in several human health effects, including bladder cancer and birth defects. New, cutting-edge research will be presented in the area of toxicology, epidemiology, chemistry, and human exposure, and the dialog between scientists of these different disciplines should significantly advance DBP research so that these important human health issues can be solved.